The Genetics of Cannabinoid Signaling: An Organismal Analysis

Summary Statement
A 2024 publication in The Lancet Neurology by Dr. Steinmeĵ and collaborators of the Global Burden of Disease
journal reviewed the prevalence of nervous system disorders worldwide from 1990-2021. Based on this
comprehensive study, it was estimated that approximately 3 billion people worldwide suffered from
neuropsychiatric and neurological disorders on a yearly basis during this time frame. From 2015-2018, adult
usage of antidepressants in the United States increased from 10 to 13% (CDC National Center for Health
Statistics, 2020). Patients suffering from depression and anxiety are traditionally prescribed selective serotonin
reuptake inhibitors (SSRIs) and antipsychotic drugs. Recent clinical studies report that cannabidiol (CBD) also
provides relief for these and other mental health disorders. However, the mechanisms of CBD action have yet
to be completely resolved. The proposed research seeks to understand the molecular-genetic mechanisms of
CBD action. From preliminary studies carried out by undergraduate research trainees and biology majors at
Harris-Stowe State University Undergraduate (HSSU), we determined that Drosophila is a tractable and ideal
model system to uncover conserved molecular-genetic mechanisms of CBD action within neuronal tissues.
Drosophila neurotransmitzers (NTs) and their receptor targets are evolutionarily conserved across invertebrate
and vertebrate species within tissues of the central and peripheral nervous systems. In addition to receptor-
targeted regulation of neuronal responses, a population of noncanonical receptors, unique lipophilic membrane
domains, and unknown targets modulate NT and CBD activity within vertebrates and invertebrates. Drosophila
does not express CB1 and CB2 receptors, but larvae respond pharmacologically to CBD making this classical
model system ideal for further investigation of offsite targets. We hypothesize that additional families of
noncanonical CBD-responsive genes, especially those important for maintaining unique populations of
phospholipids within membranes of brain tissues, function to regulate neural signaling pathways. These newly
identified noncanonical genes will be genetically placed within cell signaling hierarchies to further understand
the holistic mechanisms of CBD action. The proposed research will continue to support the mission of the HSSU
Department of Life Sciences and College of STEM to place HSSU students into competitive professional training
programs in medicine and science at the doctoral level towards boosting their success in the STEM workforce.

Public health relevance
Project Narrative Cannabidiol (CBD) is a popular, unregulated drug used to relieve the symptoms of neuropsychiatric and neurological disorders. The proposed research champions the power of genetic screening to advance an understanding of CBD function towards the development of improved therapies and guidelines for usage.